Investigating the role of CSF production and circulation in aging and Alzheimer's disease

Project Summary
The choroid plexus (CP) and cerebral spinal fluid (CSF) system serve multiple active roles in regulating brain
homeostasis and have been recently implicated in brain aging and cognitive function. Current work is focused
on cataloging molecules in the CP-CSF system and determining the role of these molecules in both brain
development as well as immune-brain interactions. CP atrophy has been observed in multiple CNS disorders,
and a recent study shows that transplantation of young CSF into aged brains reverses age-related cognitive
decline in rodents. Conditions that disrupt glymphatic circulation via CSF flow in the perivascular space have
been linked to decrease amyloid and tau protein clearance from the brain. These observations in animal and
human brain disorders indicate that the CP-CSF system plays a role in brain disease progression or
exacerbation, especially during aging. However, despite its important roles, the CP-CSF system has largely
remained an under-explored field in neuroscience due to limitations in the number of available tools to
precisely modulate its functions.
By using a novel transgenic mouse line that we recently discovered, our project will address the goals by (1)
establishing a new tool to ablate the CP in mice during the aging process and (2) study the direct causal role
of CSF production in maintaining brain health during aging and in Alzheimer's disease (AD) animal models.
Our rigorous preliminary data indicate that (1) this line can induce exclusive apoptotic cell death only in CP
epithelial cells, (2) the CP ablation results in partial to near-complete (50-90%) reduction in ventricular volume,
depending on the dose and timing of agent administration and (3) ablation of CP and loss of CSF leads to
increased accumulation of both extracellular Aβ plaques and phosphorylated intracellular protein. These
preliminary data support a direct and causal role of CSF production in protein clearance in AD animal models.
In this proposal, for the first time, we will investigate the dose-response effects of CP ablation on brain aging
with a special focus on age-related neuroinflammation, neuronal survival, age-related neurogenesis decline
and cognitive function. We will also assess the outcome of CP/CSF reduction in animal models of AD including
both Aβ and tau AD models. We will focus on AD-related pathology such as extracellular Amyloid plaque
formation, intracellular tau neurofibrillary tangles (NFTs), neurodegeneration, neuroinflammation and
cognitive function.
This project provides an essential platform for elucidating the role of CP-CSF in underlying brain aging and
Alzheimer's related cognitive decline. By establishing a new tool to remove CP-CSF in mice at any desired
timepoint (neonatal to adulthood), our project will make significant contributions and impact on promoting
studies of the CP-CSF system in a wide range of topics in neuroscience and brain diseases.

Public health relevance
The cerebrospinal fluid (CSF) and choroid plexus (CP) system conduct vital replenishment and surveillance for healthy brain functions. Abnormal CSF volumes are associated with different diseases including Alzheimer's disease (AD). The data gained in this research proposal will be directly applicable to understanding the underlying mechanisms of etiology for AD and future interventions to mitigate AD.